Developmental Funds

Developmental Funds Core: Project Summary/Abstract
Developmental Funds are a critical component of this CCSG. These funds are used to shape the future
Membership of the Koch Institute, and to ensure that the Center’s Core Facilities meet the needs of the
Membership. Developmental Funds are used in support of two distinct areas: Faculty Recruitment and
development of new Core Facilities.
The recruitment and support of early career development of new faculty is one of the principal goals of the
CCSG Developmental Funds. Historically, this has been a highly successful use of these funds, which are
leveraged with additional support from MIT. New Investigators are recruited through a stringent evaluation
process. As part of the recruitment process, a start-up package is negotiated that includes salary support,
initial equipment purchases as well as funds for laboratory operating expenses for up to three years. These
funds are necessary to allow the new faculty members to establish their laboratories and obtain independent
funding. Start-up support for new faculty came from CCSG funds (typically 1/3 of the cost) with the balance
coming from the Dean of Science or Engineering and the Provost.
The second use of these funds is for the development of new Core Facilities, in particular the expertise to
operate state-of-the-art-instrumentation and provide new leading edge services, all based on the everchanging scientific demands of Center Members. This need reflects the emergence of new technologies both
at the outset and over the course of the proposed funding period.
CCSG Developmental funds allow flexible response in both categories and they have played, and will continue
to play, a key role in leveraging non-CCSG funds.